Understanding Pandemic Evolution through Networked Data (UPEND)

PROJECT SUMMARY/ABSTRACT
There are nearly 38 million people living with HIV (PLWH) worldwide who may be vulnerable to poor
neurobehavioral and HIV-related outcomes from coronavirus disease 2019 (COVID-19), caused by severe acute
respiratory syndrome coronavirus 2 (SARS-CoV-2). Our overarching goal is to improve mental health and other clinical
outcomes for PLWH during the COVID-19 pandemic. The objective of the proposed research is to explain how COVID-
19 contributes to adverse neurobehavioral and HIV-related outcomes in PLWH and to measure the effectiveness of
vaccination as a biologic tool to mitigate COVID-19-associated neurocognitive impairment. This will help us to improve
clinical outcomes during this pandemic and inform strategies to better prepare for future disease outbreaks. We will
leverage four HIV-focused cohort studies spanning the United States, Thailand, Kenya, Uganda, Tanzania, and Nigeria
with approximately 6800 participants before the pandemic and ongoing follow-up of an additional 1000 participants in the
COVID-19 era. Aided by similarities across protocols, deidentified data and specimens will be used to achieve the
following specific aims: (1) Identify predictors of COVID-19 vaccine uptake and responsiveness in people with and
without HIV; (2) Identify clusters of determinants that impacted viral suppression and neurobehavioral health (depression
and cognition) among people with HIV during the COVID-19 pandemic; and (3) Determine long term implications of
COVID-19 on neurocognition and mortality and the impact of vaccination in mitigating these effects in people with and
without HIV. Data will undergo extensive preparation and harmonization to enable the use of advanced statistical
methods, including machine-learning approaches, to better understand the complex factors contributing to each outcome
of interest, including biologic, social, behavioral, and regional factors. We will systematically capture availability and
receipt of COVID-19 vaccinations; identify factors associated with vaccine uptake; use a centralized laboratory to monitor
for incident infections (including breakthrough) and immune responses to vaccination; and prospectively survey
participants about knowledge, attitudes, and practices related to vaccination to better define specific barriers. Throughout
the constantly evolving COVID-19 pandemic, we will evaluate changes in neurocognitive health, HIV viral load, and
CD4 count. Participants with and without a history of COVID-19, with and without COVID-19 vaccination, and with and
without HIV will be monitored for the development or progression of noninfectious comorbid conditions with a focus on
mental health and neurocognitive impairment for up to three years after infection. This research will enable us to draw
globally-relevant conclusions about the impact of COVID-19 on HIV care engagement and outcomes, extract lessons for
public health responses to COVID-19 and future pandemics, and evaluate the effects of HIV status and vaccination on
SARS-CoV-2 outcomes.

Public health relevance
PROJECT NARRATIVE The proposed research will leverage four HIV-focused cohort studies spanning the United States, Thailand, Kenya, Uganda, Tanzania, and Nigeria to quantify and describe the effects of the COVID-19 pandemic on people living with HIV (PLWH) with a focus on neurocognitive health, and to measure the effectiveness of vaccination as a biologic tool to mitigate some of these effects. In the short term, the proposed research will improve ongoing response to the COVID-19 pandemic by exploring COVID-19 contributes to adverse neurobehavioral and HIV-related outcomes, identifying individuals who are most at risk for these adverse outcomes, identifying potentially modifiable risk factors, and evaluating SARS-CoV-2 vaccination as one biological tool to improve neurobehavioral and HIV-related outcomes. In the long term, this research will inform preparedness for future pandemics, including prioritization of resources to maintain resiliency of healthcare systems, public health messaging to vulnerable and potentially hesitant communities, and strategies to improve neurocognitive health.